Identifying mTOR Dependent Periods During Brain Development

Tuberous Sclerosis Complex (TSC) is a multi-organ disorder caused by mutations in the TSC1 or TSC2
genes. TSC is a challenging disease to approach as there are many involved organ systems, which
have distinct profiles of symptom onset, disease progression, and in some cases even stability or
regression of the benign tumors known as hamartomas. These multiple examples of distinct time
courses in each organ system strongly suggest that the TSC1/TSC2 genes control cell signaling
pathways that are tissue specific and developmentally regulated, resulting in lesions that
present at different times in the lifetime of the patient. These pathways certainly include mTOR
kinase signaling, but critical upstream and downstream regulators of this developmentally
regulated process in specific tissues remain poorly understood. The neurological manifestations of
TSC are typically severe at very early ages and include epilepsy, intellectual disability, autism,
and behavioral/psychiatric disorders. Recent findings in human cell-derived model systems suggest
that neural development is disrupted in TSC, and that proper regulation of mTOR signaling is
especially important in human brain in comparison to other mammals. However, the cellular
mechanisms connecting TSC1/2 mutation and the phenotypic outcomes of this mutation are not well
understood. This project will use patient-derived cells and single-cell measurements of protein and
RNA to measure altered signaling pathways in various cell types of the human brain and also address
how these abnormalities impact specific developmental stages. Examined stages will span early
neural progenitor cells to more mature neurons found in the postnatal brain. Human induced
pluripotent stem cells (iPSCs) from patients carrying TSC2 mutations will be used to generate
lineage-committed progenitors and differentiated neurons and glia. We will also use freshly
resected human tubers as well as previously resected human tubers that have been fixed and stored,
and will employ custom-designed computational pipelines to compare the developmental trajectories
of TSC2-mutant cells to matched controls and larger published datasets. Using cutting edge cell
imaging and analysis protocols, we will test the overarching hypothesis that tubers from patients
with TSC and stem cell derivative neural cells and tissues have mTOR-dependent and
mTOR- independent signaling abnormalities that are lineage- and temporally-restricted. Finally, we
will quantitatively compare signaling dynamics in specific developmental stages and lineages
between TSC2 mutant cells and cells derived from a second “mTORopathy” with overlapping but
non-identical clinical features, to dissect the function of different components of this
pathway in neural development and pathogenesis and reveal
compensatory signaling after treatment of cells carrying TSC2 or DEPDC5 mutations.

Public health relevance
This project will use measurements of altered mTOR signaling pathways in neural cell types of the human brain and address how these abnormalities impact various developmental stages, spanning early neural progenitor cells to neurons and glia found in the postnatal brain, using patient-derived cells and models.